Defining the roles of host factors and innate immune signaling in the ocular tropism of enterovirus D70

Project summary
Enterovirus D70 (EVD70) is an understudied human enterovirus that causes acute hemorrhagic conjunctivitis,
a highly contagious and painful ocular disease and that can, in rare instances, progress to polio-like paralysis.
The molecular mechanisms underlying EVD70 infection, including 1) the host factors required for the viral life
cycle and the 2) cellular tropism within the eye, remain poorly understood, due in part to a lack of eye-specific
models. EVD70 attaches to ocular cells, at least in 2D cell culture, via sialic acids. There is, however, limited
evidence suggesting the existence of an as-yet-unidentified proteinaceous receptor for EVD70 that triggers
entry and uncoating in ocular cells. Through a genome-wide genetic knockout screen, I have identified host
factors necessary for EVD70 infection in vitro, including the orphan receptor Jumping translocation breakpoint
(JTB), which has limited demonstrated cellular functions. Notably, genetic knockout of JTB confers resistance
to EVD70. I hypothesize that JTB serves as a receptor critical for EVD70 entry and uncoating in ocular
cells and that JTB expression contributes to cellular tropism for corneal and conjunctival epithelial
cells in the eye.
The objectives of this proposal are to 1) determine the mechanism by which JTB is required for EVD70
infection and 2) define the cell-specific tropism and host immune responses to EVD70 in corneal organoids,
which recapitulate the cellular diversity and organization of the ocular surface. Aim 1 will systematically
evaluate if JTB is an entry and uncoating receptor for EVD70. Aim 2 will define the tropism of EVD70 and
investigate host responses, such as interferon signaling, in corneal organoids using unbiased single cell RNA-
sequencing and multiplexed cytokine analysis. Together, these aims will provide critical new insights into
EVD70 biology and its interaction with ocular cells. Completing the proposed aims will advance our
understanding of EVD70 molecular biology and pathogenesis and provide training to better equip me to
progress towards independence as a scientist.

Public health relevance
Project Narrative: Enterovirus D70 (EVD70) is a highly contagious human enterovirus that causes acute hemorrhagic conjunctivitis, a painful and debilitating ocular disease. This proposal aims to elucidate mechanisms by which EVD70 infects ocular cells, define the role of a novel host factor, JTB, in mediating EVD70 infection, and explore host-virus interactions in corneal organoids that model the human ocular surface. These studies will improve our understanding of EVD70 infection and identify pathways that can be targeted to develop novel antiviral therapeutics.